HUMAN STEM CELL FACTOR AND GCSF MOBILIZATION IN AUTOLOGOUS STEM CELL

It is hypothesized that Stem Cell Factor (SCF) when administered by subcutaneous injection to patients with heavily pretreated lymphoma in addition to Granulocyte-Colony Stimulating Factor (G-CSF) will allow for enhanced mobilization of peripheral stem cells (PSC) and more rapid engraftment of white blood cells and platelets following myeloablative therapy. The specific aims are: 1) To evaluate CD34+ stem cell collection in patients who receive G-CSF +/- SCF as movilization prior to PSC collection; 2) To assess the toxicity of stem cell factor when administered by subcutaneous injection; 3) To evaluate engraftment of peripheral stem cells mobilized with G-CSF +/- SCF following myeloablative chemotherapy/radiotherapy; 4) To assess quality of life in these patients.